Cellular Therapy for Type 1 Diabetes using Mesenchymal Stem Cells

:
Two major hurdles must be overcome to cure type 1 diabetes (T1D): (i) the autoimmune response and (ii) the destruction of insulin-secreting islets/β cells. Immunotherapies, including improved immune regulation using ex vivo expanded regulatory T-cells (Tregs) or low-dose interleukin-2 (IL-2), may suppress autoimmunity. However, immunomodulation is not expected to directly stimulate regeneration of β cells. On the other hand, mesenchymal stromal/stem cells (MSCs) possess both immunomodulatory and regenerative properties and represent a promising new intervention for autoimmune diseases. MSCs are an accepted therapeutic for wound healing in plastic surgery applications and are being tested in clinical trials for treating autoimmune and inflammatory diseases, ischemia-reperfusion injuries, diabetes, and other diseases. Our group and others found that after infusion into spontaneous non-obese diabetic (NOD) mice, MSCs migrated into the injured pancreas, reduced hyperglycemia, and attenuated Th1 immune responses concomitant with the expansion/proliferation of Tregs. Most importantly, MSC infusion increased mRNA expression of IL-2 and TGF-β receptors in pancreatic Treg cells in NOD mice. A pilot clinical trial in Sweden showed that a single infusion of autologous bone marrow-derived MSCs preserved insulin secretion in adult patients with new-onset T1D. This study has yet to be systemically tested in patients in the United States, and no mechanistic studies have been reported that explain the observed benefits. MSCs derived from umbilical cord (UC-MSCs) show greater cell yield, a less invasive harvesting procedure with associated reduced morbidity, and stronger immunosuppressive and regenerative potential and are a popular source for cell therapy. Based on the above principles and the successful patient enrollment in our one-year R01 grant, we propose a renewal of a randomized, double-blind, placebo-controlled, single-center clinical trial to determine the efficacy of UC-MSC therapy in patients with new-onset T1D. Our working hypothesis is that systemic administration of MSCs freshly expanded ex vivo reduces the progression of diabetes and preserves insulin secretion through restoring normal function of the immune system and preservation/improvement of pancreatic β cells in patients with T1D. We will test this hypothesis by determining the safety and efficacy of MSC therapy in patients with new-onset T1D when added to standard-of-care. MSCs may constitute an important therapeutic advancement for T1D.

Public health relevance
Project Narrative: The goal of this study is to determine the safety and efficacy of fresh metabolically active allogeneic umbilical cord-derived mesenchymal stromal/stem cells (UC-MSCs) for the treatment of new onset type 1 diabetes (T1D) and to understand any mechanisms of protection. If proven effective, such strategy can be used as a therapeutic option for T1D patients and potentially other autoimmune disorders.